The Johns Hopkins Alzheimer's Disease Resource Center for Minority Aging Research

The Schools of Medicine, Nursing, and Public Health of the Johns Hopkins University are proposing to renew
the Johns Hopkins Alzheimer’s Disease Resource Center for Minority Aging Research (JHAD-RCMAR) in
response to RFA-AG-23-025. The aims of this application are to: (1) mentor early-stage investigators from
under-represented backgrounds in minority aging and health disparities research, with a focus on Alzheimer’s
disease (AD) and AD-related dementias (ADRD), using a life course perspective encompassing biological,
behavioral, and community factors contributing to cognitive impairment and dementia in older adults from
under-represented backgrounds; (2) conduct epidemiological, preventive, and intervention research that
addresses AD/ADRD in later life within a multi-level framework that encompasses individuals, families, social
networks, and communities; and 3) engage communities and care providers – especially family caregivers,
primary care practices, communities of faith, and community organizations – as our partners in recognizing
dementia and developing interventions with the potential to prevent cognitive decline and reduce AD/ADRD
dementia risk and disparities in minority older adults. The JHAD-RCMAR consists of: (1) a Leadership and
Administrative Core whose function is to provide governance and an administrative structure, to support
research, to foster interactions between Cores and other Centers and Universities. particularly Historically
Black Colleges and Universities, and Minority Serving Institutions, and to ensure RCMAR Scientists develop
mentoring relationships across the affiliated departments, schools, and nationally; (2) a Research Education
Component to foster diverse junior investigators and mid-career investigators transitioning into ADRD-relevant
research through support for individual pilot projects, career mentoring, scholar-to-scholar interactions, and
role modeling; (3) a Community-Liaison and Recruitment Core to ensure the relevance of the AD/ADRD
research and to increase knowledge of engagement of community members in the research enterprise with the
further development of a Community Resource Institute as a venue for community-investigator interaction; and
(4) an Analysis Core as a foundation for methodological and statistical training, including education and
mentoring in mixed-methods research. An Executive Committee includes community representatives and an
External Advisory Committee consists of distinguished investigators with relevant expertise in minority aging,
disparities, and AD/ADRD. A pilot project program supported by all Cores to facilitate the development of
RCMAR Scientists includes three initial pilot projects focusing on legal needs of Black men with dementia and
their care partners; Closing the Black/White wealth gap in cognitive health; and Dementia caregiving
experiences for older parents of Asian Indian Origin in US and India. Our renewal reflects our interdisciplinary
team’s desire to continue mentoring and advancing the field of minority aging research on AD/ADRD.

Public health relevance
The burden of Alzheimer’s disease (AD) and AD-related dementias (ADRD) falls disproportionately on the populations of older adults who are from under-represented backgrounds. Research on minority aging to understand racial/ethnic disparities in AD/ADRD and to develop interventions and preventive strategies to reduce cognitive impairment and dementia risk is urgently needed. A goal of this renewal Johns Hopkins Alzheimer’s Disease Resource Center for Minority Aging Research application is to train and support early- stage investigators from diverse backgrounds who are carrying out ADRD-relevant research that supports cognitive health and well-being in older adults from under-represented backgrounds.